Regulation of entorhinal cortex layer II vulnerability by a cell-type specific miRNA

Project Summary
Neurofibrillary tangle formation and neurodegeneration occur, during preclinical Alzheimer’s disease (AD), in
remarkably restricted cell populations, in the layer II of the EC (ECII), at first in a subregion of EC, the
transentorhinal area (TEC). The reason for this selective vulnerability pattern is still unknown. It is crucial to
discover genes and pathways underlying vulnerability, because they could both yield mechanistic insight into
the disease and open new therapeutic avenues. We previously compared protein-coding genes between ECII
and various neuron types resistant to AD and uncovered a number of gene drivers of neuronal vulnerability by
building an ECII functional network. Here, using single-nucleus RNA-sequencing, we identify a micro RNA
(miRNA), miR-129-2, with a unique expression pattern that makes it a very promising candidate vulnerability
gene. It is expressed at highest levels in the TEC, might be differentially expressed between mouse and
humans, and is predicted to modulate AD pathology in the EC by our functional network analysis. Additionally,
two of its targets are extremely relevant for AD: RBFOX1, an AD genetic susceptibility factor, and MAPT, the
gene that codes for tau itself. miRNAs, by modulating expression of hundreds of genes at once can have
profound effects on cells, serving both as functional and pathological hubs. Here we propose to investigate
how miR-129-2 interferes with different aspects of AD pathogenesis and to demonstrate that it is protective
against tau accumulation. In Aim 1, we propose to map the subregions of EC where miR-129-2 is expressed,
in mouse and humans. In AD, miR-129-2 is downregulated, and we will test how early in the disease this
downregulation occurs by comparing its levels in the EC in control and prodromal AD individuals. To determine
why miR-129-2 decreases in AD, we will test its expression in AD-like contexts (Aβ, aging) in the mouse. In
Aim 2, we will study the crosstalk between miR-129-2 and Rbfox1 and how both broadly regulate AD genes in
ECII, by regulating splicing and RNA stability. We will test if miR-129-2 regulates amyloidosis and microglia
activation. Lastly in Aim 3, we will ask if miR-129-2 has a role in directly curtailing tau levels. If we validate that
this is the case, miR-129-2 will be an exciting therapeutic target that we could mimic in order to keep tau levels
at bay in ECII neurons. Systematically silencing it in AD mouse models would also generate models with more
abundant AD-like pathology in ECII neurons.

Public health relevance
Project Narrative MicroRNAs are a very particular type of RNA molecules that can regulate many cellular processes at once - including the cell’s pathological processes – and have been understudied because common genomics tool do not usually detect them. Here we serendipitously discovered that one of these microRNAs was very abundant in the neurons most vulnerable to Alzheimer’s disease, and we propose to demonstrate that it is used by vulnerable neurons to keep pathological tau in check, before it goes down as the disease unfolds. We propose to define its mode of action and investigate if it could represent a good therapeutic target for early stages of Alzheimer’s disease.